University of Rochester Intellectual and Developmental Disabilities Research Center

ABSTRACT
School-children with intellectual and developmental disabilities (IDD) are at acute risk for severe COVID-19.
Many have compromised immunological and respiratory function, cognitive impairment and complex medical
issues. Children with IDD desperately need to attend specialized schools, but this also places them at ultra-high
risk of COVID-19 exposure and infection, despite masking, distancing, and vaccination of staff. Critically, we
lack longitudinal data on development and persistence of antibody-mediated immunity to COVID-19 for children
and staff in IDD-specialized schools, including cross-strain protection, to guide development of vaccination and
policy recommendations. This supplement brings together the strengths of the University of Rochester
Intellectual and Developmental Disabilities Center and the UR RADx-UP. Under this Administrative
Supplement, we propose continuation of our prospective, longitudinal tracking of anti-SARS-CoV-2 antibodies
in over 56 IDD students and 282 staff at a specialized school for IDD children. Via RADx-UP, we currently have
7 monthly capillary blood samples per subject analyzed for anti-spike (S) and anti-nucleoprotein (N) IgG against
SARS-CoV-2 and variants, and common coronavirus strains (HCoVs: OC43, HKU1, NL63, 229E) measured
by the mPLEX-CoV research assay. We will extend this prospective, longitudinal study with an additional 12
months of sampling to capture increases and decreases in SARS-CoV-2 antibody levels. In Aim 1 we will use
multidimensional measurement of anti-SARS-CoV-2 and other coronavirus antibodies over 1 year to estimate
the rate at which antibodies decrease after vaccination and infection. We will use memory B cell studies to
estimate long-lived immune memory and multidimensional analysis of IgG immune repertoire against SARS-
CoV-2 variants. In Aim 2, we will link these data, with a comprehensive immune response genotypic and IDD
phenotypic analysis. Targeted resequencing of vaccine response genes will provide critical information on
immune response associated gene mutations (e.g. cytokine promoter polymorphisms) in neurotypical staff and
IDD children, and their influence on anti-SARS-CoV-2 antibody levels. Successful completion of this project
will identify decay rates of anti-SARS-CoV-2 IgG in vaccinated subjects, and provide new data on association
of IDD phenotyping and immune gene SNPs with vaccine responses.

Public health relevance
PROJECT NARRATIVE School-children with intellectual and developmental disabilities (IDD) are at acute risk for severe COVID-19. This study measures the level of antibodies to SARS-CoV-2 in students and staff at an IDD school, and will gather data to inform vaccination and infection prevention strategies in this vulnerable population.